Characterizing and predicting comorbidity cascade among men and women with and without HIV by harnessing data from MWCCS and electronic medical records

ABSTRACT
Older persons with HIV (PWH) face a higher risk, greater burden, and faster progression of age-related
comorbidities, including cardiovascular diseases, metabolic disorders, renal dysfunction, obstructive lung
disease, liver cirrhosis, and cancers, compared to those without HIV. These comorbidities lead to polypharmacy,
adverse outcomes, and premature death. Understanding the cascade of comorbidity events and the natural
history of these conditions among PWH is essential to guide secondary prevention and early interventions. The
MACS/WIHS Combined Cohort Study (MWCCS) has significantly advanced HIV care by providing insights into
HIV transmission, risk factors, and AIDS and non-AIDS outcomes among PWH using an interval cohort design.
We propose to enrich this data source by establishing an electronic health record registry nested within the
MWCCS (Aim 1) to study comorbidity burden and cascade among people with and without HIV. Furthermore,
we will leverage existing cohort-wide biobehavioral data and the newly linked EHR data to develop predictive
models of the comorbidity cascade among people with and without HIV (Aim 2).
The proposed R21 work directly responds to PAR-24-092 by studying the aging and comorbidities of HIV using
multidisciplinary approaches. Advanced clinical informatics tools, statistical learning models, and leveraging
existing MWCCS infrastructure and biobehavioral measurements will shed light on aging and comorbidities in
PWH. It will identify high-risk individuals prone to high comorbidity burden, thus paving the way to eventually be
able to provide guidance on clinical decision making and care. Notably, this transformative initiative will serve as
a pilot platform, leveraging MWCCS infrastructure, real-time EHR data, and existing cohort biomarkers. The data
pipeline developed through this project will provide a scalable foundation for expansion to other MWCCS study
sites in the near future, significantly broadening the scope and impact of ongoing research in HIV, aging, and
comorbidity.

Public health relevance
NARRATIVE/RELEVANCE Building on the long-standing community cohort of people with and without HIV from the MACS/WIHS Combined Cohort Study (MWCCS), we will integrate electronic health record (EHR) to enrich this interval cohort data repository. Our multidisciplinary team, comprising experts in epidemiology, clinical informatics, biostatistics, and clinical care, will employ advanced informatics tools to construct a comprehensive clinical registry. This initiative will address the burden of comorbidities and the cascade of comorbidity events in the context of people with and without HIV.